Interrogating a novel axis of tumor suppression in small cell lung cancer

SUMMARY
Small cell lung cancer (SCLC) is an aggressive cancer type with no targeted therapies available. It is critical that
we gain a better understanding of the genes that drive SCLC and that we model key SCLC subsets. Employing
genetically engineered mouse (GEM) models is central to this effort. To identify candidate tumor suppressive
and biologically important pathways, we applied genome-scale functional screens to a cellular model of early-
stage SCLC. We identified a stress activated protein kinase (SAPK) pathway, as tumor suppressive in SCLC
cellular model systems. Map2k4, Map2k7 and Jun were particularly strong screen hits. The SAPK/AP-1 pathway
is a target of deletions and mutations in human SCLC, with targeted sequencing revealing MAP2K4 deletion or
mutation in ~3% of SCLC. In human datasets, AP-1 transcriptional activity is associated with ASCL1 target gene
expression, linking this pathway to the SCLC-A subtype. Moreover, our preliminary data confirms potent
acceleration of SCLC tumorigenesis with Map2k7 deletion in a sensitized Rb/p53-deleted mouse model. In this
proposal we explore the biological roles for this SAPK axis in SCLC tumorigenesis. We will leverage study of
cellular models of SCLC, in vivo genetically engineered mouse models, and human tumor datasets to define
roles for the SAPK pathway in SCLC tumor suppression. We will generate and characterize GEM models of
SCLC with deletion in Rb/p53 along with either Map2k7 or Map2k4 to elucidate effects of SAPK suppression on
tumor initiation and progression. We will employ cellular models to interrogate the impact of SAPK perturbation
on early stage and late-stage SCLC cells. We will perform RNA-seq analyses to identify transcriptional programs
consistently regulated by a MAP2K4/MAP2K7 axis upstream of c-JUN/AP-1. These analyses will use SCLC
tumor tissue from mouse models along with isogenic SCLC cell lines with SAPK pathway perturbations. We will
also perform CUT&RUN occupancy studies to determine the impact of SAPK perturbation on genomic binding
of JUN and FOS and ATAC-seq to examine chromatin accessibility. Integrative analyses will then identify
candidate direct transcriptional targets of AP-1 relevant to tumor suppression for functional perturbation studies.
There is increasing appreciation that SCLC exhibits different subtypes based on transcriptional features. Our
preliminary data support the notion that SCLC differs in the level of SAPK/AP-1 activation, likely via both genetic
and via transcriptional suppression of pathway components. Changes in this pathway may also be linked to
neuroendocrine features and transcriptional subtype of SCLC. This proposal will elucidate an unappreciated
tumor suppressor axis in SCLC and will also help us understand factors that govern SCLC transcriptional state
and SCLC subtype.

Public health relevance
Project Narrative Small cell lung cancer (SCLC) exhibits heterogeneity in genetic alterations and transcriptional features which impact tumor progression/therapy response and, thus, are critical to understand. We performed functional screens that revealed genes in the SAPK/AP-1 pathway as exhibiting tumor suppressor activity in SCLC, a finding that we validated in vivo. Using cellular and in vivo models, we interrogate roles for this pathway in the biology of SCLC and we will complement the functional studies with analyses of human data to link alteration in this pathway to clinical responses.